WUIDDRC Supplement-Supporting the health and well-being of children with intellectual and developmental disability during COVID-19 pandemic

PROJECT SUMMARY/ABSTRACT Children with intellectual and developmental disabilities (IDD) are at major risk of irreversible harm from the Coronavirus Infectious Diseases 2019 (COVID-19) pandemic, particularly those from underserved populations. Not only are they at dramatically higher risk of becoming infected with Severe Acute Respiratory Syndrome Coronavirus-2 (SARS-CoV-2) and death from COVID-19, but children with IDD are vulnerable to the negative impact of school closure. School districts provide critical services beyond the education, including nutritional, social, therapy (physical, occupational, and speech-language) and healthcare services. Risks are heightened for children with IDD, as they are often unable to wear masks, practice social distancing and/or implement effective hand hygiene. Access to rapid and reliable SARS-CoV-2 testing is essential for children with IDD and school staff in order to safely return to school. Members of our research team have developed an innovative, scalable, low-cost method for SARS-CoV-2 testing using saliva samples. Investigators at the Washington University Intellectual and Developmental Disabilities Research Center (IDDRC@WUSTL), in collaboration with the University of Missouri-Kansas City Institute of Human Development and the Kennedy Krieger Institute in Maryland (which includes an IDDRC, the Maryland Center for Developmental Disabilities, and the Kennedy Krieger School Programs), are ideally positioned to determine the best implementation strategies to maximize use of a saliva-based SARS-CoV-2 diagnostic test for vulnerable children and school staff in a school setting. The IDDRC@WUSTL has a long-standing relationship with the Special School District (SSD) of St. Louis County, whose mission is to serve children with IDD, and the national network of the Association of University Centers on Disabilities (AUCD). First, we will determine the most effective messaging and implementation strategies to maximize weekly SARS-CoV-2 testing in a school setting. In this adaptive clinical trial, we will administer 52,000 diagnostic tests to students and school staff at SSD, whose student population is 48% Black. Second, we will measure national attitudes among parents/guardians of children with IDD and school staff regarding the impact of COVID-19 and the importance of SARS-CoV-2 testing. At the successful completion of this project, we will have improved the acceptance, adoption, and process for SARS-CoV-2 diagnostic testing in a school-based setting to enable delivery of critical educational activities for children with IDD in an underserved community. By identifying the most effective methods for SARS-CoV-2 testing in a vulnerable population of children with IDD, we will establish a blueprint for wider adoption of COVID-19 mitigation efforts, such as vaccination.

Public health relevance
PROJECT NARRATIVE Children with intellectual and developmental disabilities, particularly those from underserved populations, are at increased risk for life-threatening infection with Severe Acute Respiratory Syndrome Coronavirus-2 (SARS-CoV-2) and vulnerable to the negative impact of school closure. Investigators at the Washington University Intellectual and Developmental Disabilities Research Center (IDDRC@WUSTL), in collaboration with the University of Missouri-Kansas City Institute of Human Development and the Kennedy Krieger Institute in Maryland (which includes an IDDRC, the Maryland Center for Developmental Disabilities, and the Kennedy Krieger School Programs), are ideally positioned to determine the best implementation strategies to maximize use of a saliva-based SARS-CoV-2 diagnostic test in a special school setting and to determine national attitudes toward disease prevention. As testing capacity increases nationally, widespread testing within a school setting will become an essential tool to mitigate the impact of the COVID-19 pandemic, and our results will inform its implementation as well as that of other disease prevention strategies, such as vaccination.